Annual Meeting of the Society for Craniofacial Genetics and Developmental Biology

? DESCRIPTION (provided by applicant): Craniofacial abnormalities account for approximately one third of all congenital birth defects, are a major cause of infant mortality and dramatically impact national health care budgets. This proposal requests support for the annual meeting of the Society for Craniofacial Genetics and Developmental Biology (SCGDB). The significance of this application is that SCGDB annual meeting is the only annual interdisciplinary meeting specifically focused on craniofacial genetics, development, evolution, disease and repair. The SCGDB annual meeting brings together leading investigators to present cutting-edge unpublished research, and provides a scientific, educational and professional forum for students, post-docs, residents and fellows to discuss their science and interact with established and recognized researchers, clinical geneticists and surgeons in the field of craniofacial biology. This proposal addresses a number of the missions and aims of the National Institute for Dental and Craniofacial Research's strategic plan by promoting novel and innovative research avenues for improving critical health issues in craniofacial development as well as preventing congenital craniofacial malformation syndromes. The broad and long-term impact of the SCGDB annual conference is to facilitate the establishment of scientific collaborations (basic research and clinical), and to promote education, research, and communication about normal and abnormal development of the tissues and organs of the head, with the ultimate goal of informing clinicians in the care and treatment of patients with craniofacial conditions.

Public health relevance
PUBLIC HEALTH RELEVANCE: Head and facial abnormalities account for approximately one third of all birth defects in new born babies, are a major cause of infant mortality and dramatically impact national health care budgets. Comprehensive and well-coordinated treatments can provide satisfactory management of each head and facial birth defect. However, the results are rarely fully corrective. Hence considerable effort needs to be invested into developing therapeutic avenues of prevention and also developing better regenerative strategies for craniofacial tissue repair. This can only come from a thorough appreciation of the signals, processes and events that govern normal head and facial development. The goal of the SCGDB annual conference is to promote education, research, and communication about normal and abnormal development of the tissues and organs of the head with the ultimate goal of informing clinicians in the care of craniofacial patients. The Society for Craniofacial Genetics and Developmental Biology Annual Meeting is the only annual interdisciplinary meeting specifically focused on craniofacial genetics, development, evolution, disease and repair.